Investigating mechanosensation in the glaucomatous optic nerve head

Project Summary
The general purpose of this proposal is to provide the principle investigator (PI) with the experience and
skills necessary to become a successful and independent vision researcher. Lowering intraocular pressure
(IOP), the primary modifiable risk factor for glaucoma and the mainstay of treatment, does not halt the
progression of glaucoma in many cases. This discrepancy highlights gaps in our understanding of how IOP-
induced mechanical stressors cause damage to retinal ganglion cells (RGCs), the major cell type affected in
glaucoma. Thus, the PI’s long-term goal is to develop an independent research program dedicated to
investigating mechanisms by which RGCs and their cellular and structural support system respond to
mechanical stressors. These studies will set the stage for the development of new treatments, with the
potential to prevent RGC death regardless of IOP.
The consensus in the field is that the initial site of RGC injury occurs at the optic nerve head (ONH). Of the
cells of the ONH, astrocytes are the most likely sensors of these mechanical stressors. A prime candidate
through which astrocytes sense and respond to mechanical stimuli is mechanosensitive channels. In Aim 1,
we will test the hypothesis that astrocytes are key mechanosensors within the ONH, and that they translate
changes in surrounding stiffness and mechanical strain into alterations in ECM integrity and tissue
stiffening. In Aim 2, we will test the hypothesis that inhibition of ONH astrocyte Piezo mechanosensitive
channel activity will prevent IOP-induced astrocyte reactivity and RGC death. We will use a combination of
tissue engineering techniques, biomechanical tools, and in vivo glaucoma models to accomplish our specific
aims. By analyzing ONH astrocyte mechanosensation in glaucoma through a mentored approach, and by
acquiring a solid foundation in the fields of astrocyte/matrix biology, mechanobiology, tissue engineering,
and glaucoma model systems, the PI will uniquely position herself to identify such novel drug targets. The
success of the proposed research and career development plan is reinforced by the exceptional multi-tiered
mentoring environment at the Center for Vision Research at SUNY UMU, participation in the Syracuse
Biomaterials Institute at Syracuse University, state-of-the-art facilities, and a strongly collaborative research
community.

Public health relevance
Project Narrative Glaucoma, a leading cause of irreversible blindness worldwide, is projected to affect 100 million individuals by the year 2040. It is defined as an age-associated optic neuropathy characterized by retinal ganglion cell death; a barrier to treating glaucoma is that the mechanisms underlying cell susceptibility in this disease are very poorly understood. This proposal investigates mechanisms by which astrocytes, the primary support cells for retinal ganglion cells, sense their mechanical environment in glaucoma; the data obtained from these studies will help to develop novel therapies to treat this difficult disease.